ORTHODONTIC TREATMENT EFFECTS ON CRANIOFACIAL GROWTH

The objective of this work is to apply recently proposed vector and tensor metrics for shape and shape change to the problem of analyzing the effects of orthodontic treatment on the concomitant growth of the craniofacial complex. Statistical relationships between craniofacial form and growth history will be used to estimate the projected unaltered growth, which now goes unobserved during treatment.